BIOLOGY OF MEDULLARY THYROID CARCINOMA AND RELATED ENDOCRINE NEOPLASMS

Natural history of the three inherited syndromes of MTC, the effect of surgical and chemotherapeutic interventions at different stages of the disease, and also to provide a resource of patient specimens for basic laboratory investigations.